Evaluating unmet survivorship needs: a multilevel assessment for a broad care network

Roswell Park Comprehensive Cancer Center (Roswell Park), established in 1898 is one of a small number of freestanding, NCI-designated, comprehensive cancer centers and the only comprehensive center in New York State (NYS) outside of Manhattan. The sole mission of the Center is to eliminate cancer's grip on humanity through cancer research, treatment, prevention and education. The Cancer Center which is in its 46th year of funding, is currently organized around 4 research programs, 9 shared resources, a clinical trial infrastructure that prioritizes investigator-initiated and innovative clinical trials that are a product of the research programs and a community outreach and engagement (COE), Cancer Research Training & Education Coordination (CRTEC) that are interactive, cross-functioning and responsive to our catchment area. The Cancer Center supports 145 members and has recruited 162 new faculty since the previous review with 42 of them new members of the CCSG. Our cancer-relevant direct grant funding is currently $79M with 49% ($39M) coming from the NCI, a more than doubling of our NCI funding from 2018 with over 56% of funding in program/multi-PI type grants that underscores our commitment to collaborative research. Our high impact papers have increased to 29% from 10% in 2018 resulting in practice, paradigm and policy changing research. We have increased our focus on our community outreach and engagement, and we have an enhanced approach to our community and catchment area needs. The Specific Aims over the next 5 years are as follows: Aim 1: Innovation: To be a leader in the development of innovative approaches in cancer research across basic, clinical and population sciences to improve the quality of care for our patients in our catchment area and beyond. Aim 2: Translation: To enhance collaborative efforts between basic, clinical and population scientists toward the more effective translation of our discoveries into paradigm changing patient practices and interventions and policies. Aim 3: Education: To train and develop the next generation of scientists and physicians through innovative oncology-focused programs that continue to develop translational opportunities across the clinic, the basic science and population science areas. Aim 4: Community: To ensure that the needs and priorities of communities in our catchment area are catalyzing high- impact science with a specific focus on strategies drive rapid translation of scientific advances to reduce the cancer burden in our catchment area and beyond. Aim 5: To promote a culture of fairness, accountability, integrity and respect across our cancer center employees, scientists, physicians, nurses and healthcare staff, students and trainees and leadership toward a more productive workplace and to serve our community more effectively. Roswell Park continues to play a primary role in discovery and innovation in basic science findings that enable us to deliver the best cancer care to our patients in New York State, around the country and around the world.

Public health relevance
Roswell Park Comprehensive Cancer Center is one of only a small number of freestanding, NCI-designated, comprehensive cancer centers, and the only comprehensive center in New York State (NYS) outside of Manhattan. Roswell Park has a rich history of leadership in basic discovery, translational, clinical and population-based science in cancer research. In recent years Roswell Park has pushed the boundaries of excellence in cancer research and has experienced exponential growth in faculty recruitment, programmatic and scientific excellence, a robust clinical trial portfolio and accrual to investigator-initiated trials, population cancer science development and a broader footprint in the WNY catchment area and community. We propose here to be a leader in the development of innovative approaches in cancer research to improve the quality of care for our patients in our catchment area and beyond, to enhance collaborative efforts between scientists and physicians toward a more effective translation of our discoveries into paradigm changing patient practices and interventions and policies, to train and develop the next generation of investigators through innovative oncology-focused programs, to focus on the needs of our catchment area of WNY relevant to our cancer burden through research and outreach using effective strategies for education, prevention, treatment and survivorship and to cultivate, value and promote fairness, accountability, integrity and respect across our cancer center employees, scientists, physicians, nurses and healthcare staff, students and trainees and leadership toward a more productive workplace and to serve our community more effectively. Roswell Park continues to play a primary role in discovery and innovation that enable us to deliver the best cancer care to our patients in New York State, around the country and around the world.